Center for Undiagnosed Diseases at Stanford

ABSTRACT
The Undiagnosed Diseases Network (UDN) has increased access for patients with undiagnosed diseases to
the nation’s leading clinicians and scientists. The extension of Phase II of the Center for Undiagnosed
Diseases at Stanford will facilitate the continuation of UDN efforts toward sustainability, refinement of methods,
and integration with regular clinical practice. Here, we propose a program of study that will (1) facilitate
accurate diagnosis of patients with undiagnosed diseases; (2) improve diagnostic rates through novel
approaches to data analysis and integration; and (3) explore underlying mechanisms of disease to accelerate
therapeutic drug discovery. In Aim 1, we propose to complete clinical evaluations and associated work for
participants enrolled in the UDN at Stanford. This will include pre-visit chart review and genetic counseling
followed by an individualized visit during which standardized phenotypic and environmental data are collected.
Biosamples facilitate genomic, multi-omic, and cellular evaluation of disease. Expansion of fibroblasts and, in
selected cases, generation of induced Pluripotent Stem Cell (iPSC) lines facilitates scientific investigation of
the underlying diseases. We propose to continue implementation of novel methods in areas of high potential to
increase diagnostic yield. This includes algorithms for the detection of small genomic insertions and deletions,
structural variation and differentially methylated regions. We will continue evaluation of long-read sequencing
technologies. We will apply novel computational approaches for systematic integration of genomic,
transcriptomic, metabolomic, and phenotypic data with the entire medical literature to improve diagnostic yield.
We also propose to facilitate diagnosis through enhanced cellular and model organisms phenotyping. We will
implement immunomic approaches for undiagnosed cases with suspected immune mechanisms. In Aim 2, we
will prepare for the transition to the Phase III model of the UDN. This will include preparing both samples and
data for archiving, together with continuing network activities to enhance the value of the UDN beyond the
funding period. We will continue our efforts to seek diagnosis using available resources for all participants.

Public health relevance
NARRATIVE As the Center for Undiagnosed Diseases at Stanford in coordination with other Phase II sites of the Undiagnosed Diseases Network prepares for the next phase of the UDN, we will continue to diagnose the undiagnosed while transitioning to a new model of sustainability. Our Center will continue to bring Stanford’s technology development, genomic data analysis, stem cell biology, and translational science to the team- based diagnosis and care of patients with undiagnosed disease. We will continue to optimize the diagnostic process and integrate care of the undiagnosed into clinical practice while preserving the scientific mission of the Undiagnosed Diseases Network.